Cancer Center Administration Core

The overarching goal of the Simmons Comprehensive Cancer Center (SCCC) Administration is to provide an
efficient and effective administrative environment that nurtures and supports the Center's mission and vision.
Administration's specific goals are to deliver value-added support to Cancer Center members by providing stellar
administrative support and leadership in facilitating collaborative, transdisciplinary, and multi-investigator
research; decision-making data from its information technology platforms; strategic planning implementation,
and monitoring; and support for the other CCSG components essential to SCCC, such as shared resources,
clinical protocol and data management, developmental funds, and planning and evaluation. Administration's
services include:
• Management of the CCSG application, progress reports, and supplements
• Financial coordination and oversight, including budgeting and management of philanthropic resources
• Management of the membership processes, research and grants activities, and SCCC space
• Coordination of pilot funding mechanisms
• Oversight and management of operational aspects of the shared resources
• Representation of SCCC among UTSW institutional entities and collaboration with their representatives
• Support for faculty recruitment, retention, promotion, and tenure
• Coordination and documentation of Center meetings
• Human resource management for CCSG personnel